Enrichment-Program-001

The mission of the HDDC Enrichment Program is to facilitate advances in digestive disease-related research by organizing events that promote exchange of ideas and knowledge among HDDC Members and the Boston research community at large. The Program fosters the development of young investigators and the productivity of established investigators whose interests are consistent with the Themes of the Center. By serving as the intellectual crossroads for this research community, the HDDC Enrichment Program seeks to catalyze new research collaborations and multidisciplinary projects, and to attract talented investigators from other fields into research on the digestive tract in health and disease. Specific Aims of the Enrichment Program are: 1: To organize monthly seminars focused on each of the four HDDC Research Themes featuring HDDC members, local leaders and visiting scientists from relevant fields, with the goal of enhancing knowledge and forging connections among investigators in digestive disease research. 2: To organize annual half-day symposia and full-day conferences that feature new scientific advances and facilitate interactions and new collaborations among HDDC members, as well as non-members whose research is potentially applicable to the digestive tract. Spring Symposium topics rotate among the four major Themes of the HDDC. A biennial Frontiers in Mucosal Immunology (FIMI) conference attracts scientists from the entire Northeast. 3: To contribute to the professional training of young investigators by providing mentored public speaking and leadership opportunities in multi-lab mini-retreats, an annual Pilot Feasibility Program Retreat, focused workshops, and journal clubs. The Enrichment Program continues to have a significant impact on the careers of young investigators in the digestive diseases, to catalyze collaborations among HDDC Members, and to raise awareness of digestive diseases research in the Boston scientific community.